Organic Synthesis at the Service of Biology and Medicine

Abstract:
Dr. Ouathek Ouerfelli directs the Organic Synthesis Core Facility (OSCF) at Memorial Sloan
Kettering Cancer Center (MSK) since 2004. He is committed to continue to provide chemistry
services for the MSK research community and the development of new tools and therapeutic
agents for cancer detection, prevention, and treatment. His core services have been extended to
Weill Cornell Medical College in 2019 through an inter-institutional agreement. He possesses
more than 30 years of chemistry collaborations and service of MSK investigators, about half of
whom are NCI grantees. Along these lines, he contributed to major endeavors by eminent
colleagues who are NCI grantees such as Dr. Charles Sawyers (R01 CA155169) which led to an
FDA-approved drug, Dr. Howard Scher (P50 CA092629) with projects that are showing promise,
as well as Dr. Larry Norton (P01 CA094060) for the development of a topical treatment to chemo-
induced alopecia among others. Dr Ouerfelli maintains a state-of-the art facility with expert
professional personnel in chemical synthesis. OSCF has now the capability to support medicinal
chemistry efforts to evolve agents in support of MSK investigators. Under his leadership, the core
has greatly facilitated preclinical studies at the Center.

Public health relevance
The fundamental chemical research provided by the Core Specialist at the service of biology and medicine, if funded, would ultimately contribute to the knowledge of cancer genesis, detection, prevention, and treatment. The synergy stemming from the combination of chemical expertise with high level biology is bound to provide better understanding of disease and better treatment. The close proximity between chemists, biologists and clinicians within the nurturing and collaborative environment that is offered by MSK and WCM are a sure guaranty for success.